2025 Catecholamines Gordon Research Conference and Gordon Research Seminar

The 2025 Gordon Research Seminar (GRS) and Gordon Research Conference (GRC) on Catecholamines will take place at Grand Summit Hotel in Sunday River, Newry, Maine on August 23rd-29th, 2025. This small conference, held every other year, is an ideal forum for exploring new developments in the field of catecholamines. The major objective of the GRS and GRC is to provide a forum for trainee and investigators to learn about and discuss state-of-art and novel catecholamine neurobiology, to include both basic catecholamine function and dysfunction. The meeting will include topics spanning molecular, cellular, systems and behavioral levels of analysis with relevance to nervous system disorders that have major societal impacts including addiction disorders, mental health and neurological disorders. To meet this objective, the conference will include two keynote speakers, Dr. Patricia Janak and Dr. Veronica Alvarez who are leaders in the field of catecholamine neurobiology. Further, the preliminary program includes current topics: 1) Catecholamine Functions in Innate and Learned Behaviors, 2) Catecholamine Systems in Neurodegeneration and Aging, 3) Neurodevelopmental Mechanisms in Catecholamine Circuits, 4) Next Generation Technologies to Probe Catecholamine Systems, 5) Catecholamine Circuits in Psychiatric and Addiction Behaviors, 6) Synaptic and Neuromodulatory Mechanisms in Catecholamine Systems, and 7) Catecholamines in Pain and Nociception. While we include a session on next generation tools, catecholamines researchers have been on the forefront of applying novel technologies, thus, many of the talks and posters include the latest, cutting-edge-tools combined with conceptually innovative topics. Overall, the conference will provide a unique opportunity to discuss recent advances in the understanding of how catecholamine systems contribute to the pathophysiology and treatment of those conditions.
Another major objective of the conference is to provide an outstanding environment for the next generation of scientists to be exposed to state-of-the-art research. To meet this objective the conference provides an opportunity for junior investigators and trainees to interact with established investigators in a relaxed and scientifically stimulating atmosphere. Additionally, career development is integral to all aspects of the program, including mentor-mentee matching, poster matching, and poster judging by senior investigators, and incorporating early career speakers and discussion leaders into the program. This objective ensures that the conference has a wide-reaching impact on how future generations of neuroscientists view these scientific topics in the catecholamine field.

Public health relevance
The catecholamines dopamine (DA), norepinephrine (NE) and epinephrine have critical functions in the central and peripheral nervous systems. Alterations in catecholamine function contribute to human central nervous system disorders including addiction, neuropsychiatric (schizophrenia, depression, anxiety), and neurological (Parkinson’s disease, Alzheimer’s disease). The GRS and GRC Catecholamines will highlight leading research in catecholamine neurobiology as well as in catecholamine function and dysfunction that can lead to unique advances in our understanding of human diseases.